2024 Enzymes, Coenzymes and Metabolic Pathways Gordon Research Conference and Seminar

Project Summary
This proposal seeks partial support for the 2024 Enzymes, Coenzymes, and Metabolic Pathways GRC/GRS.
These meetings are scheduled for July 27–28 (GRS) and July 28–Aug 2 (GRC) at the Waterville Valley Resort,
in Waterville Valley, NH. The “Enzymes” GRC/GRS is the paramount conference for scientists investigating the
structure and function of enzymes and their role as the metabolic basis of diseases ranging from cancer to
neurodegeneration. The long-term goals of these conferences are to facilitate methodological, intellectual, and
interpersonal connections borne from the characterization of enzymes’ roles in life’s essential biological
processes. To reach these goals, the GRC has developed a technical program of 36 speakers (28 invited and 8
selected from poster abstracts), and the GRS has assembled a program of 9 speakers (1 invited and 8 chosen
from poster abstracts) as well as a Bioscience Careers Panel consisting of ~5 leaders from various backgrounds.
These oral presentations will disclose the most recent findings in enzymology, experimental method
development, as well as how these are implicated in disease. The GRC Chairs have emphasized that these
scholars derive from a diverse and inclusive backgrounds: with more than half of the scheduled speakers being
women, while several others are from underrepresented groups. The disciplinary program will ensure
participants are intellectually diverse – with sessions centered on neurobiochemical enzymology and method
development, and also drug discovery for both infectious and non-infectious diseases. As such, we anticipate
recruiting attendees from a similarly wide expanse of diverse backgrounds. In addition to the speaking slots,
afternoon poster sessions provide an opportunity for all attendees to share their discoveries with the broader
scientific community. Of particular importance is that these poster sessions encourage close interactions among
both junior and senior investigators, which we further reinforce by having senior investigators aid in judging
poster presentations by all participating trainees. This proposal has high significance because the “Enzymes”
GRC is a pivotal conference for researchers investigating the mechanisms of biochemical reactions where, as
yet unpublished findings at the forefront of the fields of biochemistry and biophysics are shared. A major outcome
of these conferences will be the further expansion of the community of researchers investigating how enzymes,
co-enzymes, and metabolic pathways contribute to the development of new therapeutics, especially for the
treatment of infectious diseases, cancer, and CNS dysfunction.

Public health relevance
Project Narrative Enzymes and coenzymes enable almost all metabolic transformations within organisms. For this reason, knowledge of enzymes often plays a key role in the amelioration of diseases, both infectious and non- infectious. A major focus of enzymologists is to understand enzymatic transformations, in terms of both mechanism and cellular context, to treat and/or cure specific diseases. How these processes occur and what can be done to manipulate them to improve human health are central topics of our meeting.